Adolescent alcohol and cannabis transitions: Associations with multidimensional SES and cannabis policy

PROJECT SUMMARY/ABSTRACT
Adolescents currently engaged in substance use often co-use (e.g., both alcohol and cannabis; AC co-use),
yet few have systematically examined how youth AC co-use patterns change over time (e.g., additive or
substitution effects) in differing recreational cannabis policy contexts. Particularly as it relates to
environmental opportunity and social inequality, factors like socioeconomic status (SES) and may play a
critical role. This project will inform prevention intervention strategies, specifically for young people engaged
in alcohol use, by examining the intersection of comprehensive socioenvironmental opportunity and state-
level cannabis policy, and their associations with adolescent AC co-use transitions. The aims are to identify
latent profiles and longitudinal transition patterns of AC co-use, and to examine how AC profiles and transition
probabilities are associated with multidimensional SES (mSES) and state-level recreational cannabis law
(RCL) in two different policy environments. Disaggregating patterns of AC co-use in young people is essential
to informing public health and clinical practice, as each year more states enact RCLs, and on-the-ground
providers largely operate without information about how to navigate changes in use patterns among this age
group. An exploratory aim will evaluate sociodemographic characteristics in these highly diverse samples
(Mage=16.8; 55% Hispanic/Latino; 10.6% sexual and gender minority status). Here, the applicant will maximize
data from two of her primary mentor's NIAAA-funded longitudinal R01s of underage youth engaged in alcohol
use (N=710) collected across two regions with differing RCLs. The training plan is designed to provide a rich
program of training in advanced longitudinal modeling, adolescent development, contemporary issues in
addiction, and an initial exploration into how patterns may differ for underrepresented and underserved youth.
The proposed project is a natural extension of the applicant’s current program of research, and critically,
would provide essential protected research and training time to develop requisite skills and hone expertise to
launch a career as an independent NIH-funded scientist. Without the F31 support, the applicant will need to
take on teaching obligations in her department, rendering it far more difficult to achieve this same degree of
crucial breadth and depth in training, particularly around writing and dissemination efforts. The applicant will
be mentored by Dr. Feldstein Ewing (Sponsor, University of Rhode Island; URI), an expert in adolescent
addiction and its prevention and treatment. Drs. Manshu Yang (URI) and Tammy Chung (Rutgers University)
will also provide training in AC co-use, latent variable modeling, and longitudinal methods. Drs. Feldstein
Ewing, Yang, and Chung have an over decade of work successfully collaborating, even while housed at
different institutions, supporting a synergistic training environment that will work closely with the applicant to
ensure that she meets and achieves all proposed research and training aims.

Public health relevance
PROJECT NARRATIVE Disaggregating longitudinal patterns and correlates of alcohol and cannabis (AC) co-use in young people who are already engaged in alcohol use is essential to informing potential targets for clinical and public health intervention, particularly for providers in states navigating the emergence of novel recreational cannabis laws (RCLs). The F31 applicant will identify latent profiles and transition patterns of adolescent AC co-use (e.g., additive or substitution effects) and examine how multidimensional SES (mSES) and cannabis policy context are associated with these trajectories. The training plan is designed to provide rich training in adolescent development, addiction, advanced longitudinal modeling, and an initial exploration into differential patterns for underrepresented youth, providing critical protected research time for the applicant to build and launch a career as an independent NIH-funded scientist.